Developing an Optimized Conversational Agent or "Chatbot" to Facilitate Mental Health Services Use in Individuals with Eating Disorders

PROJECT SUMMARY/ABSTRACT
Eating disorders (EDs) are serious mental illnesses associated with high morbidity and mortality, clinical
impairment, and comorbid psychopathology. Although evidence-based treatments for EDs have been
established, the treatment gap is wide. Indeed, <20% of individuals with EDs receive treatment. We need a
novel solution not only to identify individuals with EDs but also to encourage mental health services use and
address treatment barriers. I have established a strong working relationship with the National EDs Association
(NEDA), the U.S.'s leading non-profit for EDs, to offer our group's online, evidence-based EDs screen on the
NEDA website. Over one year, the NEDA screen was completed >200,000 times. Among screen respondents,
the vast majority screen positive for an ED, but of those, most are not in treatment, and only a small
percentage click to learn more about one of the options for seeking intervention presented in the screening
feedback. I propose a research agenda to design a conversational agent or “chatbot” that is optimized to
increase mental health services use among individuals with EDs through such features as: 1) providing a
personalized recommendation for seeking intervention; 2) engaging the user in motivational interviewing to
overcome barriers to care; and 3) repeated check-ins with the user to encourage follow-up with care. This
research agenda aligns with NIMH's focus on services research and interest in technology-driven approaches
to promote engagement with care. I will conduct two studies. First, I will utilize a user-centered design
approach to create a prototype chatbot and conduct usability testing with adults with EDs to inform chatbot
refinements (Aim 1). Second, I will conduct a randomized optimization trial with adults who have completed
screening on the NEDA website and screen positive for an ED but are not in treatment to determine chatbot
feasibility and to generate data on the effect of the chatbot on motivation for treatment post-initial chatbot use
and motivation for treatment and mental health services use at 1- and 3-month follow-ups (Aims 2 & 3). This
trial will employ the Multiphase Optimization Strategy framework, using a 23 full factorial design, to randomly
assign participants to a combination of the three proposed intervention components (n=8 conditions) to isolate
the active ingredients. These aims support my training plan in which I will receive expert mentorship and
training in: services research and implementation science (Training Goal 1); user-centered design and
usability testing, as well as exposure to machine learning (Training Goal 2); novel trial designs (Training Goal
3); and advanced statistical techniques for analyzing longitudinal trial and digital innovation data (Training
Goal 4). My expert mentorship team, along with the environment of Washington University, will ensure my
success. Results from the proposed study will be used to optimize the chatbot, which I will then test in a
subsequent R01 randomized controlled trial. This K08 will equip me with the skills to become a leader in
addressing the research-practice and treatment gaps for EDs, with a focus on digital innovations.

Public health relevance
PROJECT NARRATIVE Eating disorders are serious mental illnesses, but less than 20% of individuals receive treatment. I propose a research agenda to design a conversational agent or “chatbot” for increasing mental health services use among individuals with eating disorders, with study data being used to optimize the chatbot for a subsequent R01 randomized controlled trial. This K08 will not only result in the development of a highly scalable solution for facilitating mental health services use among individuals with eating disorders that has potential for widespread dissemination through partnership with the National Eating Disorders Association, but it will also result in an independent research program that addresses critical gaps in the treatment of eating disorders, with a focus on digital innovation solutions.